Reward, Salience and Value Processing in Youths at Risk for Psychosis: The RSVP Study

PROJECT SUMMARY
Schizophrenia and its clinical risk states are characterized by both positive and negative symptoms.
Positive symptoms in schizophrenia comprise hallucinations and delusions; among teens and young adults at
clinical high-risk (CHR) for psychosis, these are subthreshold in nature (e.g., perceptual disturbances and
unusual thoughts). Negative symptoms in schizophrenia and CHR include anhedonia (the reduced experience
or expectation of pleasure) and avolition (a severe reduction in motivated, goal-directed behavior). Prior work
in schizophrenia suggests that both types of symptoms may result from impairment in salience processing,
which is the appropriate evaluation of the importance and relevance of diverse experiences for normative
learning and decision-making. Adaptive salience is the appropriate response to good or positive experiences;
its blunting has been linked to both anhedonia and avolition. Positive symptoms in schizophrenia have been
associated with aberrant salience, which is the inappropriate assignment of importance to neutral events.
In this proposal, we will study salience processing and symptoms in CHR individuals, who have evolving
pathophysiology and minimal antipsychotic exposure. We will, for the first time, study both adaptive and
aberrant salience together in a CHR cohort sufficiently large (N = 96) to allow simultaneous examination of
both negative and positive symptoms, who will be followed prospectively for clinical and functional outcome.
We will use fMRI and computational modeling of reinforcement learning and decision-making to capture
quantitative behavioral and neural correlates of: (Aim 1) blunted adaptive salience (and associations with
negative symptoms); and (Aim 2) heightened aberrant salience (and associations with positive symptoms). In
longitudinal study (Aim 3), we will determine the extent to which these two types of salience processing predict
future and/or track change in symptom severity and functional outcome. Exploratory analyses will use all
behavioral, imaging, and clinical data to determine if some salience subconstructs may contribute to both
positive and negative symptoms.
This proposal is significant for several reasons. There are, as yet, no robustly effective treatments for the
CHR syndrome, which has significant current morbidity related to its positive and negative symptoms (in
addition to cognitive deficits). Also, the CHR syndrome offers an opportune window for preventive intervention
related to worsening symptoms and function and has the added advantage of minimal confounding by illness
chronicity and antipsychotic medication use. Finally, if we find that the neural and behavioral mechanisms
involved in salience processing are associated with negative and positive symptoms, this offers a promising
novel target for treatment of both types of symptoms across the schizophrenia spectrum.

Public health relevance
PROJECT NARRATIVE Both the psychotic-like symptoms and the motivational deficits characteristic of schizophrenia, including its risk states, may be related to impairments in the processing of salience or importance. Psychotic-like symptoms may result from aberrant salience, which is giving undue importance to neutral events or stimuli, whereas motivational deficits may result from blunted adaptive salience, which is not giving enough importance to what may be good or pleasurable. In this proposal we will study, over time, young people at risk for schizophrenia, in whom both types of symptoms are evolving, to determine the extent to which forms of “salience processing” may be related to their symptoms and function.